Preclinical evaluation of physical and biological interventions to reduce post- traumatic joint contracture

PROJECT SUMMARY
Post-traumatic joint contracture (PTJC) causes debilitating loss of motion following joint injury and is particularly
impactful in the elbow. Clinical treatment is limited due to a poor understanding of key mechanisms leading to
motion loss, making treatment targets elusive. This study will use a validated preclinical animal model of PTJC
to identify the key aspects of physical- and biological-based interventional strategies that best limit PTJC
following injury. Early joint remobilization improves range-of-motion (ROM); however, clinical practice requires a
period of joint immobilization following injury to reduce instability and prevent joint overloading. The parameters
of active therapy (i.e., initiation, duration, intensity) that best limit PTJC after an initial immobilization period
without destabilizing or overloading the healing joint remain unknown. In addition, while studies have shown that
modulation of the inflammatory response can improve healing after joint injury, and that T-cell-mediated signaling
might represent a particularly effective target, protocols guiding inflammation-based therapeutic approaches for
PTJC remain poorly defined. Overall objective: identify fundamental aspects of physical and biological treatment
strategies (i.e., initiation, duration, intensity, synergy) that prevent the development of PTJC using a preclinical
animal model and multi-modal, machine learning (ML)-based analyses. Aim 1: Identify parameters of
voluntary active physical therapy that are most critical to minimizing PTJC while promoting healing after
joint injury. This study will determine the optimal implementation of active physical therapy protocols to best
preserve ROM yet limit load-induced damage. Image-based ML algorithms will be used to automate/accelerate
spatial analysis of joint tissues and advance clustering analyses to elucidate cell- and tissue-level responses to
physical treatments. Hypothesis: moderate intensity/duration physical therapy will maximize motion and limit
joint damage, with additional benefit achieved by implementing a slightly staged increase in intensity after joint
remobilization. Aim 2: Develop biological strategies to reduce PTJC using anti-inflammatory intervention
and targeted modulation of the T cell mediated immune response following joint injury. Anti-inflammatory
prevention strategies will be developed and strategically combined with physical therapy to target multiple
phases of immune-mediated biological activity. ML algorithms will combine multi-modal experimental data to
explore spatial relationships in PTJC pathophysiology. Hypotheses: (i) reducing inflammation in the post-injury
and post-remobilization periods will help preserve ROM; (ii) improved outcomes from blocking T cell activity will
demonstrate a key mechanism of PTJC etiology; (iii) ML-driven data analysis will determine that abrogation of
capsule fibrosis, reduced remobilization-induced ligament hypertrophy, and limited T cell activity will be most
predictive of preserved joint function. While results obtained using an animal model aren’t directly translatable to
human care, this study will greatly advance understanding of PTJC pathophysiology and elucidate key principles
of physical and biological interventional strategies that can be leveraged to inform future treatment of PTJC.

Public health relevance
PROJECT NARRATIVE Post-traumatic joint contracture (PTJC), a common clinical problem following injury that leads to permanent stiffness and debilitating impairment, is especially challenging in the elbow because of high susceptibility and a lack of adequate treatment options. This study will use a preclinical animal model and machine learning-based computational tools to optimize physical therapy strategies and anti-inflammatory drug treatments for elbow PTJC. The long-term result of this work will be to elucidate key concepts and fundamental principles that optimize rehabilitation/treatment following injury and lead to decreased occurrence/impact of elbow PTJC.